ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Administrative Core Description The administrative core coordinates research and training objectives of the Center. The aims of this core are to provide administrative leadership, support for fiscal grant accounting and writing, meeting organization, oversight of the pilot project mechanism, facilitation of hiring of new faculty, construction and maintenance of a website, coordination and organization of data for assessment, statistical consultation, and assistance with compliance issues.